Mechanisms of Peripheral Nerve Injury and Recovery in a Zebrafish Demyelination Model

PROJECT SUMMARY
In the peripheral nervous system, axons innervate distant targets in an exquisitely patterned
network for sensation and motor control. Schwann cells, the myelinating glia of the vertebrate
peripheral nervous system, provide essential trophic support and enwrap axons to support rapid
conduction of action potentials throughout the body. In demyelinating neuropathies such as
Guillain-Barré Syndrome, peripheral myelin is broken down and cleared by mechanisms that are
not fully characterized, with impaired remyelination by injured Schwann cells. Development of
therapies to prevent demyelination and promote remyelination is hindered by an incomplete
understanding of these processes, in part because there are few models that assess glial-
specific injury and demyelination.
The goal of this project is to characterize cellular and molecular mechanisms of Schwann cell
demyelination and identify factors that promote peripheral remyelination. To accomplish this
goal, we have developed a novel larval zebrafish model in which we can chemically induce
Schwann cell demyelination to visualize nerve damage and repair over time, in living organisms.
In the first aim, we will test the hypothesis that Schwann cell demyelination results in secondary
axon damage, recruitment of macrophages, and expression of the transcription factor c-Jun in
injured Schwann cells. In the second aim, we will test the hypothesis that Schwann cell
remyelination is dependent upon both the transcription factor Mitf and axon health. We will also
test small molecules for enhancement of remyelinating potential, which can serve as candidate
therapeutics for demyelinating disorders in humans.
Altogether, our study employs a novel and highly tunable system to manipulate Schwann cell-
specific damage and repair in peripheral nerves. Our system permits visualization of myelin
sheath breakdown and reformation at high resolution, in real time, using non-invasive
fluorescent microscopy. Ultimately, this study will define key factors driving myelin dynamics in
disease states, which improves our understanding of both Schwann cell biology and treatments
for demyelinating disorders.

Public health relevance
PROJECT NARRATIVE Loss of myelin in peripheral neuropathies and nerve injuries can result in debilitating pain and motor dysfunction. Our study uses a novel zebrafish model that allows us to visualize mechanisms and consequences of myelin loss in peripheral nerves. We will use this model to identify factors that drive formation of new myelin sheaths, which are foundational for novel therapies to treat peripheral neuropathies.